Investigator Development Core

ABSTRACT
The BBRC RCMI Investigator Development Core (IDC) seeks to create a mentorship framework that is cyclical
and sustainable to empower senior postdoctoral fellows and early-stage investigators (ESI) to acquire
professional development skills, pilot funds for generating preliminary data, and skillsets for the writing and
submission of extramurally-sponsored research grant proposals. To this end, in this renewal period, the IDC
aims to create a new Mentor Incentive Program based on evidence that demonstrates its effectiveness in
empowering senior investigators to train and mentor ESI in professional and career development activities.
Importantly, Aim 1, which is focused on mentorship, will create the incentive program for ten senior
investigators, who will each serve for one year as a Designated BBRC Mentor and become part of a mentoring
triad consisting of the ESI, the mentor and the IDC Director to conduct a structured mentorship program. The
IDC will also provide the ESI with access to a pool of Affiliate Mentors that fit well with the identity, research
expertise, and proposed skills development plan of the mentee. Aims 2 and 3 provide plans for pilot project
support for senior postdoctoral fellows and ESI, and training in grantsmanship, respectively.